Translational Pathology

ABSTRACT: TRANSLATIONAL PATHOLOGY SHARED RESOURCE
The TP facility is a multi-component SR that integrates human and non-human histopathology services to
facilitate and coordinate studies for LCCC members. TP provides expertise and techniques focused on either
pre-clinical (AHC) or clinical (TPL) specimens and facilitates translation of results between the two. Each
component is led by board-certified faculty pathologist (MD, DVM, PhD) who oversees operations and long-
term planning. AHC provides comprehensive animal pathology support to investigators, from study design
through specimen handling, grossing, routine and specialized histologic techniques, bloodwork, urinalysis,
molecular characterization of tissue, and tissue morphologic analysis. The AHC component director Stephanie
Montgomery, DVM, PhD is expanding the core and its capabilities by initiating a novel training program in
veterinary pathology in combination with UNC sister University NC State and its Veterinary School. TPL, under
Dr. Sara Wobker, MD, supports clinical studies by providing access to formalin-fixed, paraffin-embedded
tissues from UNC Hospitals Surgical Pathology archives, start-to-finish translational pathology project
management, and histopathology services. Both components are equipped with instrumentation for routine
pathology but have upgrades for high level digital pathology and analysis. New technology for single cell
analysis including the Geo Max from Nanostring is being incorporated into the SR to aid in understanding the
tumor microenvironment.
The facility is well used by 109 total users of which 78 (72%) are Center members. The facility is well-
supported by chargebacks, receiving 57% of their fiscal year 2019 operating revenue from that source. TP is
requesting $186,872 from the CCSG or 12% of the operating budget. TP has supported 200 peer-reviewed
publications during the last funding cycle of the CCSG including cancer therapeutics, immunotherapy, nutrition
and cancer, nanotechnology, cancer cell signaling, gene therapy, novel cancer models, and personalized
medicine.